THE PURPOSE OF THIS MODIFICATION IS TO EXERCISE OPTION PERIOD TWO (2); EXERCISE OPTION ITEM 1 FOR OPTION PERIOD 2 (INVEST FELLOWSHIP AMOUNT); AND, ADD

International Research and Training Program Support Services